Mechanochemical mechanisms of intestinal villus development and regeneration

PROJECT SUMMARY
Intestinal villi comprise a mesenchymal core ensheathed by an epithelial layer that together increase the
intestinal absorptive surface area nearly 100 fold. Damage to villi incurred by irradiation, chemotherapeutics, and
many gastrointestinal maladies cause villus atrophy, resulting in nutrient malabsorption and digestive
complications. Remarkably, in many cases atrophied villi fully regenerate to restore their finger-like morphology,
yet in other situations the regenerative process is impaired, resulting in persistent villus atrophy. How villi
regenerate their morphology and why this process can fail are unknown. Moreover, we lack an understanding of
how mammalian villi are initially built during development. The long-term goal of this project is to understand how
signals and forces are integrated to sculpt mammalian villi during development and regeneration so as to improve
strategies for growing and regenerating human intestinal tissue.
Villus formation initiates in the embryo with the aggregation of mesenchymal cells adjacent to the overlying
epithelium that form condensations, termed villus clusters. While villus clusters seem to be required for villus
morphogenesis, the mechanisms underlying their formation have not been identified. Here, I explore a link
between these events that first build villi in the mammalian embryo during development and those that rebuild
them in the adult during regeneration. First, I quantify the physical properties of villus clusters and test whether
mesenchymal condensation into clusters, and the subsequent buckling of the epithelium into villi, is initiated
through mesenchymal cellular contractility and reinforced by differential interfacial tension. Next, I examine the
genetic mechanisms underlying the mechanics of these mesenchymal condensation events and villus formation.
Specifically, I put forth and test a model generated from single-cell RNA sequencing data wherein the contractile
activities of the subepithelial mesenchyme are triggered by Endothelin-dependent Ca2+ signaling, and the
contractions become coupled locally between neighboring cells through gap junctions to drive cluster formation
and epithelial buckling. Finally, I test whether subepithelial mesenchymal cells utilize similar mechanochemical
mechanisms to regenerate villus architecture in response to damage in the adult intestine, and additionally,
characterize villus regeneration at single cell resolution to identify new genetic mediators of adult villus
architecture. Together, these studies will define how signals and forces interact to form and reform mammalian
intestinal villi, identify new therapeutic targets to stimulate villus regeneration, and, more broadly, will address
the question of how tissue shape and size are regenerated.

Public health relevance
PROJECT NARRATIVE Villi are finger-like structures that increase the surface area of the intestine 100-fold and are required for proper nutrient absorption. Despite the fact that many types of damage to and diseases of the intestine impact the integrity of villi, resulting in nutrient malabsorption, we do not understand the determinants of villus architecture. The central goal of this project is to understand how molecular cues and mechanical forces are integrated to sculpt villi during their development in the embryo and to rebuild them during regeneration in the adult so as to inform future endeavors toward engineering functional intestines ex vivo or stimulating the regenerative process in vivo.